More than the money: how assets and stressors shaped depression across racial/ethnic groups during COVID-19

PROJECT SUMMARY
While the COVID-19 pandemic upended daily life for most people, the economic and mental health effects of
the pandemic and its consequences have not been borne equally. With the economic fallout from the
pandemic falling disproportionately on racial and ethnic minorities as well as women, it is possible and likely
that mental health disparities are widening between the groups with access to assets relative to groups without
assets. In the case of the COVID-19 pandemic, which has led to what has been called the most unequal
recession in history, it is possible that the gaps in mental health will widen over time, particularly for persons
with overlapping marginalized identities that historically reported greater burden of depression and less access
to assets. Our previous work shows that unequal access to assets, in part as a result of historical and
structural exclusion of racial minorities from wealth accumulation, may explain differences in patterns of
depression across racial and ethnic groups. Several unknowns remain: (1) the effects of stressors and multiple
assets on depression across race/ethnicity, gender, and age groups across the COVID-19 pandemic and at
the intersection of these identities, (2) trends in stressor exposure and depression incidence over the course of
the COVID-19 pandemic, and (3) the influence of assets at different levels (e.g., individual, household, and
neighborhood) in protecting against depression by group status. This Ruth L. Kirschstein National Research
Service Award (NRSA) Individual Predoctoral Fellowship (Parent F31) application builds on preliminary
research that the investigator has conducted and aims to understand the influence of stressors and assets on
depression during the COVID-19 pandemic at multiple timepoints across different and intersecting groups. The
proposed work, grounded in an eco-social framework, will use data from two original surveys, including (1) a
probability-based, nationally representative, longitudinal sample collected in March-April 2020 and 12-months
later in March-April 2021 and (2) a probability-based urban sample collected in November 2020-April 2021 that
includes geospatial data facilitating spatial analysis of neighborhood assets. Together, these datasets will allow
for assessment of the role of stressors and assets at multiple levels in shaping the risk of depression during the
COVID-19 pandemic and the accompanying economic downturn as well as the disparities in depression that
have grown due to growing gaps in economic status. Understanding how social and economic contexts
intersect with multiple identities, be they racial/ethnic, gender, or age, can inform policy and medical
interventions to address the rising mental illness in the U.S. while also informing decision making following
other largescale events in the future towards the end of reducing disparities in mental illness.

Public health relevance
PROJECT NARRATIVE This project aims to understand patterns in changes in depressive symptoms in U.S. adults at multiple timepoints during the COVID-19 pandemic across race/ethnicity, gender, and age groups, and the intersections of these identities with assets. We will measure the influence of stressors and the role of multi- level context (such as assets at the individual, household, and neighborhood levels) on mental health and how access to different assets varies across groups. Analyses aim to inform potential interventions that may target populations at elevated risk for depression during and after the COVID-19 pandemic.